University of Arizona Cancer Prevention Clinical Trials Network

PROJECT SUMMARY
The University of Arizona Cancer Prevention Clinical Trials Network (UA CP-CTNet) is at the forefront of
advancing cancer prevention through early-phase clinical trials, with a focus on five major organ systems: skin,
gastrointestinal, lung and upper aerodigestive, breast and gynecologic, and prostate and other urologic cancers.
With strong scientific and academic leadership from Lead Academic Organization (LAO) at the University of
Arizona has partnered with George Washington University and 20+ highly collaborative nationally recognized
Affiliate Organizations (AOs), UA CP-CTNet rigorously evaluates preventive agents designed to prevent or
intercept cancer at its earliest stages. High-impact studies led by the network have contributed to HPV vaccine
guidelines, evaluated the preventive potential of low-dose apalutamide in prostate cancer, and are targeting at
risk patients such as organ transplant recipient, populations including smokers, and community groups including
firefighters. Additionally, UA CP-CTNet is exploring innovative strategies, such as topical immune modulators
and microbiome-modifying agents, to prevent skin and cervical cancers. The four core objectives of UA CP-
CTNet are: (1) to execute scientifically rigorous early-phase trials that target key molecular pathways involved in
cancer prevention across these five organ systems, ensuring trials are aligned with the most current scientific
advancements; (2) to characterize the clinical activity and biological effects of preventive agents, focusing on
molecular targets, immune responses, and key carcinogenesis markers to assess their potential efficacy and
safety; (3) to enhance trial efficiency and inclusivity by leveraging modern statistical and trial design methods
and by employing a multipronged process involving stakeholder and investigators to consider eligibility and
participation barriers and recruitment strategies toward optimizing access and inclusion; and (4) to formalize the
UA CP-CTNet training and professional development pipeline to foster the growth of future leaders in cancer
chemoprevention. Through these objectives, UA CP-CTNet aims to generate critical early phase clinical and
biomarker guided efficacy and safety evidence on promising prevention agents that will drive forward cancer
prevention efforts, influence public health policies, and ensure that future cancer prevention research continues
to benefit diverse populations and at-risk groups.

Public health relevance
PROJECT NARRATIVE Advances in the molecular understanding of cancer development and progression, encompassing genomic, metabolic, and immune hallmarks, have driven the investigation of a growing number of agents aimed at intercepting the early stages of cancer for prevention purposes. The primary objective of the University of Arizona Cancer Prevention Clinical Trials Network (UA CP-CTNet) is to conduct early-phase clinical trials to evaluate the biological effects of potential preventive agents and to identify clinically relevant correlates that indicate agents with favorable safety profiles and preliminary efficacy. The scientific and clinical evidence generated from these trials will play a crucial role in determining the viability of further clinical development of these agents for cancer prevention.